Steric-blocking AntiSense Oligonucleotide (ASO) Discovery to Selectively Correct NF1 Haploinsufficiency

PROJECT ABSTRACT. Neurofibromatosis (NF1) is an autosomal dominant genetic disorder impacting 1 in
3000 births, including over 2M people worldwide, with symptoms including ‘benign’ tumors, bone dysplasia,
cognitive/social deficits, and a very high pre-disposition to both cancers and cardiovascular disease. Current
therapeutic approaches target specific downstream components of NF1 signaling, for example MEK inhibition
in tumors, failing to address the broad range of signaling and symptoms associated with NF1. Given that NF1
is characterized by haploinsufficiency (e.g., lack of functional NF1 protein), and also that miRNA's have been
shown to regulate NF1 protein levels (Paschou 2012; Zhu 2020), we propose here to develop specific RNA-
targeted anti-sense oligonucleotides (ASOs) to promote increased NF1 protein levels, with the goal of
normalizing downstream signaling (Ras, etc.) and thus alleviating NF1 symptoms at the root cause of disease.
We propose this as a novel path of NF1 drug discovery, with potential impact on a broad range of NF1 patients
and symptoms, in a preventative manner, and one that is applicable to the wide spectrum of unique NF1
genetic mutations already identified.
Research Background. Increasing NF1 protein expression via transfection has been shown to reverse
abnormal Ras activation resulting from NF1 protein loss (Wallis, 2018; Mellert, 2018). Also, increased protein
expression in other genetic conditions such as Willams-Beuren Syndrome, and Supravalvular Aortic Stenosis,
compensates for haploinsufficiency (Giordano, 2012). Lastly, overcoming haploinsufficiency in other autosomal
dominant conditions (Sim1; Pax6 genes) has shown an ability in vivo to correct symptoms (Matharu, et. al. 2019;
Rabiee, 2020). NF1 expression is regulated by multiple miRNAs, providing the opportunity to identify and target
miRNAs that regulate NF1 protein expression in key cell types. Development of RNA-targeted ASO’s could lead
to selectively blocking this repression and correcting NF1 haploinsufficiency.
Specific Aims. 1) Using in silico analysis (e.g., TargetScan application and publication reviews) we identify 34
candidate miRNAs, and in SA1 target determining the ability of each to regulate NF1 expression across three
key cell types relevant to NF1. 2) Based on top miRNA candidates, design and validate steric-blocking ASOs
that selectively block miRNA-mediated inhibition of NF1 expression in NF1 disease-relevant cell types. Validate
increased NF1 protein expression across three NF1 relevant cell types. 3) Once increased expression of NF1
protein is established, validate that NF1 steric-blocking ASOs further normalize NF1-dependent signaling utilizing
immortalized Schwann, primary fibroblast and iPSC-derived NF1+/- cells, evaluating the following: a) impact on
Ras/mTOR signaling (pERK, ELK-1, AKT, etc.), and b) impact on cell proliferation. Program goal is to prioritize
2-3 candidate ASOs for an SBIR Phase 2 pre-IND evaluation.

Public health relevance
Project Narrative Neurofibromatosis Type 1 (NF1) is an autosomal dominant genetic disorder impacting an estimated 1 in 3000 people worldwide, and which is characterized by a complex set of symptoms that are highly dependent on NF1 protein haploinsufficiency (e.g., the lack of sufficient functional NF1 protein). With strong and published evidence that NF1 expression is inhibited by miRNAs, we propose to design steric-blocking antisense oligonucleotides (ASOs) that selectively block miRNA-mediated repression of NF1 expression, upregulating NF1 protein levels, and thus correcting cell proliferation and NF1-dependent signaling pathways (e.g., Ras- MAPK and mTOR,) known to be dysregulated by mutations in the NF1 gene. ASOs successfully designed and validated using this approach to improve NF1 haploinsufficiency in vitro will provide valuable NF1-targeted therapeutic candidates for further drug development.